Identifying molecular mechanisms contributing to disease etiology and the neurological symptoms associated with pediatric DPD deficiency

PROJECT SUMMARY
Dihydropyrimidine dehydrogenase (DPD) deficiency, caused by mutations within DPYD, has been
studied mostly in the context of 5-fluorouracil (5-FU) toxicity and its role as a pharmacogene. However, a rare
pediatric disorder with severe early onset symptoms, pediatric DPD deficiency, is also linked to genetic
variation within DPYD. The molecular mechanisms that contribute to disease onset and associated symptoms
are unknown, nor have any effective therapeutic avenues been identified, likely owing to the lack of
mechanistic knowledge. Therefore, in the proposed studies, I will use induced pluripotent stem cell (iPSC)-
derived cerebral organoid models of pediatric DPD deficiency to identify the mechanisms linking DPD
deficiency with the outward symptoms of the condition. The overall goals of the proposed studies are to define
disease etiology, determine molecular mechanisms that lead to disease onset, and to identify potential
therapeutic targets. We hypothesize that dysregulation of excitatory and inhibitory signaling within the
brain contributes to seizure onset and epilepsy due to excitotoxicity and a decrease in β-alanine
inhibitory signaling, along with anatomical structural changes across development and differences in
cellular composition. We further hypothesize that the symptoms of this disorder could be relieved by
correcting genetic variation within DPYD. To address this hypothesis, we will identify differentially expressed
genes and dysregulated pathways at bulk RNA sequencing (RNA-seq) and single-cell RNA sequencing
(scRNA-seq) levels to determine molecular mechanisms contributing to the disease. We will investigate the
potential for dysregulation of gene expression via epigenetic mechanisms and perform functional studies of
organoid signaling. Finally, isogenic cell line models will be established to determine if the molecular and
functional phenotype of organoids derived from affected patients is specifically dependent on DPYD genetic
variation. Overall, these data will describe the etiology of pediatric DPD deficiency, determine molecular
mechanisms and pathways contributing to symptom onset, and aid in therapeutic target identification for
disease treatment. These studies will provide broad implications into the role of DPYD in neurological
development and developmental mechanisms contributing to pediatric genetic epilepsy onset.

Public health relevance
PROJECT NARRATIVE Genetic variation within DPYD contributes to the early onset disorder pediatric DPD deficiency, resulting in severe metabolic, developmental, and neurological side effects. The proposed studies will identify the mechanisms through which deficiency of DPD contributes to the dysregulation of neurotransmitter systems, including alterations to excitatory glutamatergic and inhibitory GABAergic signaling, leading to the symptoms associated with pediatric DPD deficiency.